Transdisciplinary Training in Sleep and Circadian Research

ABSTRACT
This proposal is for the competing continuation of the Colorado Transdisciplinary Training in Sleep and Circadian
Rhythms T32 program. The primary aim is to prepare outstanding pre-(PhD) and post-(PhD, MD/PhD, MD)
doctoral fellows for science careers that address cutting-edge basic and clinical research questions that
represent the future of biomedical research. The training program will foster transdisciplinary research with state-
of-the-art technologies and rigorous methods used by participating faculty laboratories and will evaluate and
enhance the mentoring skills of faculty. The program is novel in that it exposes trainees and faculty from diverse
biomedical research backgrounds to collaborative sleep and circadian science. Similarly, current sleep and
circadian trainees and expert faculty benefit from meaningful interactions with investigators from different
research backgrounds, particularly those from biomedical research areas that are of high importance to the
NIH/NHLBI. The program will train three pre-doctoral and two post-doctoral fellow positions yearly. The research
training activities of the 21 participating faculty emphasize transdisciplinary training in sleep and circadian
rhythms with research programs based in physiology and analysis across major levels of physiological
organization from molecules to the whole organism physiology including: genetics/genomics, microbiome,
metabolomics, proteomics, sleep, circadian rhythms, cardiovascular, stress physiology, neuroscience/neurology,
immunology, endocrinology, metabolism, and integrated physiology. Faculty research activities also include
biomarker development, computational biology/bioinformatics, biomathematical modeling, mechanistic and
intervention clinical trials, and study of pediatrics/development, aging, epidemiology, obesity, diabetes, mental
health, and pulmonary sciences and critical care. Because our goal is to provide transdisciplinary and
translational research career training, major program components of this T32 include the Department of
Integrative Physiology, the Department of Psychology and Neuroscience, and the Institute for Behavioral
Genetics at University of Colorado Boulder, multiple clinical departments and divisions at University of Colorado
School of Medicine Anschutz Medical Campus and the Department of Applied Mathematics and Statistics at the
Colorado School of Mines and the Department of Health and Exercise Sciences at Colorado State University.
The existing fruitful and collaborative environment is a strength of this training grant. Of the existing T32s in
Colorado, this is the only one dedicated to transdisciplinary sleep and circadian science and represents the only
formal T32 sleep and circadian science training program in the western United States.

Public health relevance
Public Health Relevance Insufficient sleep and circadian dysregulation cause, promote and exacerbate major medical health problems such as cardiovascular disease, obesity, diabetes, depression and respiratory disorders. The number of investigators being trained in transdisciplinary sleep and circadian research cannot keep pace with the accelerating health-care problems associated with insufficient sleep and circadian dysregulation. This training program will increase the number of researchers in the pipeline and facilitate the development of the next generation of scientific leaders; and thereby, this training program will ultimately contribute to knowledge of integrative physiological mechanisms and the treatment of disease that will advance the health and well-being of the public.